Leveraging Longitudinal Data and Informatics Technology to Understand the Role of Bilingualism in Cognitive Resilience, Aging and Dementia

Project Summary
Alzheimer’s Disease and Related Dementias (ADRD) along with other age-related
neurodegenerative diseases contribute to significant morbidity and costs for the aging population
worldwide. Advances in this field have uncovered that bilingualism is a protective factor that
delays onset of ADRD and may enhance cognitive reserve. Still, little is clearly known about the
direct impact of bilingualism on cognitive reserve and ADRD progression; multiple, entangled
confounding variables, such as lifestyle and psychological resilience, complicate the relationship
between bilingualism and cognition and warrant further investigation. Other major shortcomings
in previous studies include small sample size, lack of population diversity and insufficient data on
relevant covariates. We aim to address these critical gaps via the following specific aims.
In Aim 1, we will leverage advanced informatics and longitudinal electronic health records (EHRs)
from millions of patients across three geographically and demographically diverse sites (i.e., MGB
[Boston, MA], UTHealth [Houston, TX], and UC Davis [Sacramento, CA]). We will develop robust
algorithms to identify potential monolingual and bilingual cohorts and their phenotypes. We will
disseminate reproducible informatics methods to support research cross-institutionally.
In Aim 2, we will conduct a prospective cohort study to evaluate the dynamic cognitive changes
in monolingual and bilingual older adults. We will explore potential pathways by which bilingualism
impacts cognitive decline over time using comprehensive instruments and surveys to repeatedly
measure cognitive resilience, cognitive reserve, and related factors, including social support,
psychological resilience, and physical activity.
In Aim 3, we will develop and validate machine learning algorithms to identify onset of age-related
cognitive decline and dementia using EHR data. We will apply the validated language classifier
for all participating EHR systems to examine the role of bilingualism in relation to the progression
of cognitive decline and the effect of other factors recorded in EHR data.
By integrating multiple disciplines to explore the influence of bilingualism on cognitive reserve,
this proposed design will address major gaps and challenges in this field. Such research has the
potential to transform the current understanding of neural and behavioral pathways in relation to
language, culture, and environment. Furthermore, the knowledge gained may translate to
improvements in existing interventions and novel therapeutic approaches for ADRD.

Public health relevance
Narrative With a growing aging population worldwide, Alzheimer’s Disease and Related Dementias (ADRD) is expected to affect nearly 14 million Americans alone by 2060, contributing to long-term disability, reduced quality of life, and substantial healthcare costs. We will utilize large longitudinal electronic health record (EHR) data from three prominent academic centers and advanced informatics technology to thoroughly investigate the role of bilingualism on age-related cognitive health outcomes. We will develop informatics methods to assist with extensive screening, recruitment, and in-depth analysis of phenotypic information collected from both patient surveys and EHR data, while exploring novel pathways by which bilingualism influences cognitive reserve, or the ability to cope with neurological stress, in elderly bilingual and monolingual adults.